U-RISE at City College of New York

The goal of the proposed U-RISE program is to further increase the number of qualified
undergraduates from underrepresented groups who continue their education at the Ph.D. level
in the biomedical and behavioral sciences. The project will consist of activities that represent a
coordinated program that includes undergraduate recruitment, extensive research experience,
and graduate school preparation. These activities are centered around research training and
mentoring, coupled with specific courses for the U-RISE trainees to prepare them for the rigors
of postgraduate training. The intended trainee outcomes are that all trainees earn their BS
degree, receive extensive research training in a host laboratory so that they better understand
how to frame and address scientific questions, present their work at local and national
conferences, co-author a publication, increase their self-perception and confidence as
scientists, and apply and be admitted to graduate programs. We will recruit students for
placement into the laboratories of faculty in the departments of Biology, Biomedical
Engineering, Chemistry & Biochemistry, Earth & Atmospheric Science, Physics, and
Psychology; the pool of mentors also includes faculty from the CUNY School of Biomedical
Education and the CUNY Advanced Science Research Center. Students will be appointed for
their final 2-3 years of undergraduate study. They will engage in mentored independent
research; have regular advising and scientific meetings with their student peers, mentor, and
the U-RISE program director and advisory committee; and will participate in professional
development seminars. We will also partner with other CCNY training programs to provide
mentoring development workshops for our faculty mentors. We will leverage our partnerships
with community colleges in the City University of New York system to identify potential
trainees, and with institutions in New York City such as the New York Structural Biology
Center, Memorial Sloan-Kettering Cancer Center, or Columbia University Medical Center to
offer expanded training opportunities for our students. The implementation of the new U-RISE
program will benefit top science students, both trainees as well as non-trainees, thereby
meeting the goals of strengthening the capability of the college to train students in the
sciences, and enhancing their research training experience at City College.

Public health relevance
The goal of the proposed U-RISE program at the City College of New York is to further increase the number of qualified undergraduates from underrepresented groups who continue their education at the Ph.D. level in the biomedical and behavioral sciences. This will enhance public health by increasing the pool of biomedical scientists working to study the underlying bases of biological phenomena and diseases.